Core B - CMS Data Core

OTHER PROJECT INFORMATION – Project Summary/Abstract
Core B: CMS Data Core
The CMS Data Core acquires, manages, enhances, and makes available for researcher use a rich collection of
claims data from the Centers for Medicare and Medicaid Services (CMS). The NBER’s existing CMS database
consists of Medicare claims for all beneficiaries covered by traditional fee-for-service Medicare over the last 35
years. Incremental goals of this continuation are to add Medicare Advantage (MA) and Medicaid records, and to
enhance the data to better support studies of Alzheimer’s Disease and Related Dementias (ADRD), and racial
and ethnic disparities in health and healthcare. Working with Core C, we will incorporate in our CMS databases
state-of-the-art measures of ADRD symptoms and diagnosis, stages of dementia, and cognitive impairment;
state-of-the-art identifiers for patient and to some extent provider race and ethnicity; and likely spousal
identification as potential caregivers. There are substantial interactions between Cores B and C, as the
methodological implementation of existing algorithms and advances in ADRD and race/ethnicity measurement
developed under Core C will be incorporated in our CMS database infrastructure under Core B. To accomplish
these aims, we will draw on our extensive experience working with the underlying claims records, newly informed
by additional Program Project collaborators with relevant expertise in ADRD patient care, ADRD and dementia-
related measurement, and racial disparities research. The core also administers all CMS data security systems
and assures that all resources developed from this grant and other NIA-supported research at the NBER are
hosted or linkable from the NBER public use data archive. These NBER’s CMS data infrastructure will be used
extensively in the research projects proposed here and in roughly 200 other projects that we expect CMS will
authorize to reuse the NBER database over the next five years.

Public health relevance
OTHER PROJECT INFORMATION – Project Narrative The CMS database infrastructure managed by this core is among the richest resource anywhere for research on the healthcare and health of older Americans, including those with Alzheimer’s Disease or related dementias (ADRD). In this continuation, the database will be enriched still further with the addition of Medicare Advantage and Medicaid records; state-of-the-art measures of ADRD symptoms and diagnosis, stages of dementia, and cognitive impairment; state-of-the-art identifiers for patient and to some extent provider race and ethnicity; and potential caregiver identification.